Cancer Prevention and Control

CANCER PREVENTION AND CONTROL PROGRAM
PROJECT SUMMARY/ABSTRACT
The Cancer Prevention and Control (CPC) Program has the overall goal to engage in scientific discovery
across the cancer control continuum (i.e., primary prevention to survivorship) that translates into empirically-
based interventions, clinical and public health practice, and policy strategies to reduce the cancer burden in
New Jersey and beyond. CPC provides the platform for productive, collaborative, and impactful science, and
interfaces with the Cancer Center for the translation of that science. CPC research centers on three main foci:
1) epidemiological research that evaluates environmental, neighborhood, heath care system, and behavioral
risk factors and biomarkers and molecular tumor characteristics, which predict disparities in cancer risk,
treatment, quality of life, and survival; 2) development of efficacious methods to reduce cancer risk behaviors
and improve cancer outcomes through individual, family, and system-level interventions, and; 3) evaluation of
tobacco use and development of efficacious smoking cessation interventions in vulnerable populations.
Program members are organized into three groups based on expertise and relevance to the three aims. The
CPC Program has 26 members who conduct extramurally-funded cancer prevention and control research in
eight departments and three schools. Since 2011, CPC members have published 544 peer-reviewed
manuscripts, with 22% intra-programmatic, 9% inter-programmatic, and 70% collaborative with other
institutions. The CPC Program is home to ten fully cancer-focused, peer-reviewed funded research projects
equivalent to an NIH R01 from nine different, independent PD/PIs. Members were awarded $6 million (annual
direct costs) overall in cancer-relevant grant funding (five multi-PI), with $4.6 million (direct costs) from NCI.
CPC has senior leadership with the appointments of Cristine Delnevo (tobacco) and Elisa Bandera
(epidemiology) as Program Co-Leaders. In collaboration with the Associate Director for Cancer Prevention,
Control, and Population Research, Sharon Manne (former program co-leader), the CPC’s research on cancer
epidemiology, behavioral interventions to improve individual, family, and system-level outcomes, and tobacco
control has expanded in breadth, depth, and extramural funding base. The CPC Program includes health
psychologists, epidemiologists, primary care physicians, and public health scientists who collaborate on multi-
disciplinary investigation across the cancer control continuum (e.g., primary prevention to survivorship). This
research translates into empirically-based interventions, clinical and public health practice, and policy
strategies to reduce the cancer burden in New Jersey and beyond. The multidisciplinary nature of CPC is
reflected in the collaborative grants and publications.
CPC, Part I: Narrative, Page 1 of 1; DRAFT 1/19/18 2:59 PM